Student Career Enhancement Project

ABSTRACT
Significant resource and infrastructural disparities hinder Native populations’ access to the health and public
health services enjoyed by the general U.S. population. To develop culturally relevant approaches to building
healthy communities, more Native health professionals and researchers are needed for Native Nations to
exercise their sovereignty and to achieve health equity. Yet, for aspiring health professionals on rural
reservations, education and training opportunities are limited. From 2017-2020, the Navajo Native American
Research Center for Health (NARCH) Partnership’s SEP built and institutionalized key components of an
educational pathway for Navajo students, specifically a Bachelor of Science degree in Public Health (BSPH) at
Diné College and the Indigenous Health concentration within the Master’s in Public Health (MPH) program at
Northern Arizona University (NAU). These programs are foundational to the infrastructure needed to conduct
relevant, evidence-based health research and provide essential public health services to the Navajo people.
Informed by SEP evaluation, recognizing the need to cultivate a generation of pre-college students to select
public health and health research as a profession, and identifying the importance of professional development
at the undergraduate, graduate and post-doctoral levels, the overarching goal of Navajo NARCH SEP
(2021-2025) is to build and sustain an “education to profession pathway” pertinent to health research
and public health needs of the Navajo Nation. The Navajo NARCH SEP specific aims are to: 1) Expand
NARCH collaborations with high schools and related organizations to inform and expose students to the roles
and career paths of health-related professions; 2) Expand the Diné College BSPH program by developing
additional local research experiences, strengthening academic skills and alignment with graduate programs,
and building connections across six campuses on Navajo Nation to better support student learning and
development; 3) Adapt the NAU MPH program Indigenous Health (IH) concentration, to align with the practice
and research needs of the Navajo Nation Department of Health, Indian Health Service and Diné College and 4)
Mentor recent Navajo post-doctoral fellows or Early Stage Investigators to build skills for successful, externally
funded research careers focused on health equity for the Navajo Nation. SEP will leverage existing academic
and professional partnerships and coordinate with the NARCH Administrative Core and pilot research projects
to provide experiential learning and training opportunities with on-going and community-based projects.
Engagement with health services and active research allows students to apply their knowledge and build
professional contacts. Project impact will be tracked quantitatively, through student enrollment, degrees
awarded, accomplishments (job placement, graduate school and grants submitted) and qualitatively, through
student voice documenting factors associated with academic success and application of learned skill sets.

Public health relevance
NARRATIVE The Student Enhancement Project of the Navajo NARCH Partnership will build and sustain an education to profession pathway that applies the strengths and addresses needs for culturally relevant, research informed public health and health services within the Navajo Nation. Courses and webinars that use culturally-relevant frameworks and methods, service learning activities that provide practical experience and reinforce networks, and an internal system of mentorship will engage high school, undergraduate, and graduate students, and early career investigators to build skills and develop innovative strategies to advance health equity for the Navajo people.